Treating T cell immunodeficiency among older adults by a recombinant Foxn1 fusion protein

Project Summary
With modern advances in medicine, our average lifespan is increasing. However, advanced age is
often accompanied by chronic diseases Our immune systems frequently plays a central role in the
development of chronic diseases and T cells play a critical role in the immune system, providing protection
against infection and cancer. The thymus, the primary organ for T cell development, however, undergoes a
profound age-dependent atrophy, a process called thymic involution. Thymic involution results in T cell
immunodeficiency, leading to increased susceptibility to infection and cancer, and difficulty in establishing
protective immunity via vaccinations. Currently, there is no effective way to prevent or reverse T cell
immunodeficiency among older adults. T cell development in the thymus is dependent on the thymic
microenvironment, in which thymic epithelial cells (TECs) are the major components. However, TECs undergo
qualitative and quantitative loss that is the major factor responsible for thymic atrophy.
FOXN1 is a pivotal regulator for TEC development and maintenance, and we have shown that
recombinant (r) FOXN1 fusion protein that contains FOXN1 and a protein transduction domain (PTD) can
translocate from the cell surface into the cytoplasm and nucleus. Intrathymic (i.t.) injection of the rFOXN1
fusion protein into mice increases the number of TECs, and, consequently, enhances thymopoiesis and
increases the number of T cells in the periphery. However, the i.t. injection route is impracticable for human
application. Development of a more practicable regimen in term of the route of administration is necessary.
The goal of this proposal is to develop new rFOXN1 fusion proteins that can migrate into the thymus to
enhance thymopoiesis after intravenous (i.v.), intramuscular (i.m.), or subcutaneous (s.c.) injection into old
mice. In the R21 phase, we will produce rFOXN1 fusion proteins containing FOXN1-PTD and thymus targeted
peptides, or thymus/TEC specific receptor or antibody (Aim 1). We will then determine the ability of the
rFOXN1 fusion proteins to migrate into the thymus when injected i.v., i.m. or s.c. (Aim 2), and to increase the
number of TECs and T cells in old mice (Aim 3). If the R21 milestones are met, the R33 phase will be
undertaken. Aim 4 will further characterize the thymus and the peripheral T cell function in the rFOXN1 fusion
protein-treated old mice. In Aim 5, we will determine whether T cells in rFOXN1 fusion protein-treated old mice
are immune tolerant to self-antigens to prevent autoimmunity. Aim 6 will analyze rodent toxicology and
pharmacokinetics of a lead rFOXN1 fusion protein. Our long-term goal is to use the lead rFOXN1 fusion protein
to prevent and treat T cell immunodeficiency in older adults, thus leading to improved healthcare outcomes and
mortality rates.

Public health relevance
Project Narrative T cell development in the thymus depends on the thymic microenvironment, of which thymic epithelial cells (TECs) are the major component. However, TECs undergo a qualitative and quantitative loss over time, which results in thymic involution and T cell immunodeficiency in older adults, leading to increased susceptibility to infection and cancer, and difficulty in establishing protective immunity via vaccination. The purpose of this project is to develop novel recombinant Foxn1 fusion proteins and to determine the ability of the proteins to rejuvenate the aged TECs, and subsequently to enhance T cell generation in old mice.